Longitudinal cohort of mushroom intake and cognitive function in the elderly

Project Summary/Abstract:
The overall goal of this project is to determine the association of mushroom intake with cognitive
function in a middle-aged and elderly cohort conducted in Aichi Prefecture, Japan. Healthy diets are associated
with reducing the risk of cognitive decline and there is a need to identify specific foods that delay or reduce
cognitive impairment in the elderly. Mushrooms are foods that contain several beneficial ingredients that have
shown to reduce cognitive decline in animal studies, possibly through anti-oxidant and anti-inflammatory
pathways. Mushrooms are infrequently consumed in the United States and their effects in humans have been
understudied. We showed in the National Health and Nutrition Examination survey that in persons over age 60
who participated in a battery of cognitive tests, mushroom consumers evidenced higher scores and better
cognitive function. Mushrooms are fungi, and contain unique compounds not found in plants and animals.
Mushrooms contain high concentrations of ergothioneine, a thiohistidine betaine amino acid that is a powerful
antioxidant. In particular, the ergothioneine transporter OCTN1 gene is a specific transporter for the uptake of
ergothioneine to cells and tissues experiencing oxidative stress. Mushrooms also contain high concentrations
of glutathione (GSH), the most abundant intracellular antioxidants in humans. The traditional Japanese diet,
which includes mushroom consumption, is associated with a lower risk of cognitive decline in the Ohsaki
Cohort 2006 Study. We have the opportunity to study the individual effects of mushrooms and their key
constituents in the Japanese National Institute for Longevity Sciences-Longitudinal Study of Aging. This is a
multi-wave cohort study conducted in men and women ages 40-79 who have been followed for age-related
health effects including cognitive measures. The study uses detailed questionnaire, medical records, and
nutritional assessments. There are several reasons why the NILS-LSA is the ideal population for our
hypothesis. Mushrooms are consumed by a higher percent of the population in Japan and in greater daily
amounts than in the U.S. In addition, the ergothioneine content of mushroom species consumed in Japan is
higher than the white button mushrooms typically consumed in the U.S. Our specific aims are:
1. Determine the relationship between mushroom intake and a battery of neurocognitive outcomes including
cognitive function, dementia, and depression. Based on 24-hr food recall data, mushroom intake at baseline
and at success waves will be examined prospectively using generalized equation models in relation to a
battery of cognitive measures including medically determined clinical dementia, the Wechsler Adult Intelligent
Scale (WAIS-R digit span test), the Mini-Mental State Examination, and clinical depression.
2. Determine the relationship between ergothioneine and GSH levels and risk of neurocognitive measures
using baseline blood samples for a subset of 309 participants. Causal mediation analysis will be conducted to
determine the direct effects of mushroom and indirect effects attributed to ergothioneine and GSH.

Public health relevance
Project Narrative Aging is associated with a decline in cognition and the onset of disabling diseases such as dementia. The current investigation will investigate whether mushrooms consumption is associated with reduced incidence of cognitive decline in a cohort of middle-aged and elderly individuals.